Gene Expression in Long-Term Memory

Maintaining and promoting healthy cognitive functions, of which memory is a most important one, is
one of the major goals of mental health research. Diseases, stress, injury and aging can lead to
cognitive and memory impairments. It is estimated that up to one third of adults will experience a
gradual decline in cognitive function known as mild cognitive impairment as they age. Furthermore,
a number of diseases such as Alzheimer's disease, autism, mental retardation are associated with
memory impairments. Thus, minimizing or preventing cognitive and memory impairments is a very
important goal in mental health. A principal approach toward this goal is to understand the
physiological mechanisms of memory formation, persistence and storage and identify molecular
mechanisms and targets that can be used to enhance memory, not only for potentiating normal
functions but also for developing strategies that may prevent or reverse memory loss. Using rat and
mouse models, we have identified the growth factor insulin like growth factor 2 (IGF-2) as a potent
memory and cognitive enhancer in healthy conditions. Using models of memory impairment in both
developmental disorders and aging we found that IGF-2 significantly reverses memory losses. Our
studies of the last 5 years also started elucidating some of the action mechanisms by which IGF-2
promotes memory enhancement and reverse memory deficits. One of these mechanisms emerged as the
autophagy/lysosomal degradation system, a key regulator of cell functions. Furthermore,
investigations of mechanisms of memory formation and enhancement in cortical regions provided
evidence for slow-developing learning-induced changes distinct from the known synaptic plasticity.
This proposal aims at continuing these mechanistic investigations in order to: 1- Determine the
role of autophagy/lysosomal degradation in memory consolidation and IGF-2-mediated memory
enhancement, as well as their critical target mechanisms; 2- Determine identity and regulation of
novel biological mechanisms occurring in cortical areas following training that are critical for
memory consolidation and enhancement; and 3- Determine the role of myelination in long-term memory
formation. Results from these studies should significantly advance our knowledge of brain
plasticity mechanisms, which may be targeted to achieve memory enhancement and to treat cognitive disorders.

Public health relevance
Capitalizing on recent findings from our ongoing studies using rats and mice as animal models this project continuation aims at identifying the role of autophagy/lysosomal degradation in memory formation and enhancement and of novel biological mechanisms occurring in cortical areas following training that are critical for memory consolidation and persistence. This understanding may significantly help preventing or reversing memory loss which is a most important goal in mental health research.